2023 Biology of Aging Gordon Research Conference and Gordon Research Seminar

Project Summary
This application requests funds to support the 2023 Gordon Research Conference (GRC) on the Biology of
Aging, to be held at Rey Don Jaime Grand Hotel in Castelldefels (Spain) on July 2–7, 2023, and the Gordon
Research Seminar (GRS), which will be held at the same location on July 1–2, 2023, immediately prior to the
GRC. This will be the sixteenth Biology of Aging meeting since its origin in 1962. While geriatrics and
gerontology societies and their conferences have focused on the medical, social, and psychological
consequences of aging, in the most recent two decades there has been an explosion of knowledge on
underlying mechanisms of the aging process. While the biology of aging is still a relatively new field, this GRC
has become the premier forum for unpublished data presentation and discussions, resulting in a meeting
where one can view exciting current science and see the future directions of the field. This meeting is unique in
its diversity, reflected in the theme of the 2023 conference: “Evolving concepts of organismal aging”. Aging
research over the past decades has made great strides to identify key hallmarks of aging at an increasingly
detailed molecular and cellular resolution. These advances have led to the growing recognition that aging is
malleable and subject to interventions not just at the cellular level or in invertebrates but possibly in a range of
vertebrates and even humans. At the same time, rapid advances in technology and the expansion of the
experimentally tractable model organisms have facilitated the study of aging from an ever-broader perspective
of entire complex organisms. These studies paint a much more intricate picture of systemic aging, and they
offer unprecedented new insight into interactions between host defense, the central nervous system,
microbiota, and the process of aging. This GRC will highlight some of these emerging top-down approaches to
understanding aging with a focus on immune aging, neural control, and the microbiome.
Participating scientists will present basic studies in invertebrate model organisms, as well as studies in higher
organisms. Appropriately, the talks and posters will reflect the diversity of the biology of aging by ranging from
molecular studies to understanding how aging impacts numerous cellular and organ systems and organisms.
We will also hear exciting work on interventions to modulate aging. The meeting will incorporate a panel
discussion, mentoring lunch, and numerous networking opportunities. Our multifaceted approach to meet the
objectives of this meeting include: i) A program rich in scientific diversity of topic and approach; ii) An atmosphere
to promote interdisciplinary collaborations and stimulate scientific exchange; iii) Mentoring opportunities to
promote interactions between junior investigators and senior, established investigators; and iv) Support of
individual diversity in participation.

Public health relevance
Project Narrative Aging research over the past decades has made great strides to identify key hallmarks of aging at an increasingly detailed molecular and cellular resolution. These advances have led to the growing recognition that aging is malleable and subject to interventions not just at the cellular level or in invertebrates but possibly in a range of vertebrates and even humans. This meeting will highlight diversity in aging research, incorporating cutting edge experimental approaches, discoveries, and will span model organisms to humans.